Coagulation-inflammation crosstalk in placental abruption

PROJECT SUMMARY/ABSTRACT:
Placental abruption is a life-threatening pregnancy complication where the placenta completely or partially
separates from the uterus before the birth of the baby. Abruption complicates 1 to 2% of all births; two-thirds
are classified as severe based on associated maternal and perinatal morbidity and mortality. Numerous studies
suggest that abruption is a culmination of early ischemic pathology involving blood coagulation and
inflammation. However, disease onset and mechanisms involved in its progression into abruption are poorly
understood and constitute an important gap in knowledge. A well-recognized barrier is that human placental
tissue cannot be obtained until pregnancy is over, making early pathology and its progression challenging to
investigate. Our preliminary data demonstrate that mice deficient in Endothelial Protein C Receptor (EPCR), an
endogenous inhibitor of blood coagulation, exhibit decidual blood clots that progress into placental abruption.
We have discovered that this process requires thrombin receptor Par4 and is accompanied by infiltration of
leukocytes and evidence of their acute inflammatory reaction involving (1) release of myeloperoxidase (MPO),
an enzyme that generates toxic oxidants, and (2) histone citrullination, a posttranslational modification of
histones that changes chromatin structure and drives inflammation. Importantly, our data shows that MPO-
release and citrullination of histones also occur in human placental abruption, supporting the relevance of our
findings. Taken together, these new findings suggest that activation of the blood clotting cascade results in
recruitment of immune cells to the decidua, and that their ensuing inflammatory response mediates placental
abruption. The long-term goal of this research is to identify cellular and molecular components of this
coagulation-inflammation crosstalk in the setting of maternal thrombophilia, and to identify potential therapeutic
targets to inhibit progression into placental abruption. The objective of this application is to test the hypothesis
that onset of decidual blood clots and progression into placental abruption requires thrombin receptor
activation, recruitment of MPO-expressing leukocytes and activation of their downstream mechanism of injury.
Specific aim 1 will identify and phenotype altered immune cell populations in the decidua, and their trafficking
to and from the decidua during onset and development of placental abruption. Specific aim 2 will dissect the
roles of coagulation components and the vascular endothelium in onset and progression to placental abruption.
Specific aim 3 will identify mediators of inflammation in the pathogenesis of placental abruption with particular
emphasis on the roles of neutrophils and MPO, and their destructive cycle of oxidative stress and chronic
inflammation. The expected outcome is a comprehensive understanding of immune cells that are recruited to
the decidua in the context of activated coagulation and identification of their downstream mechanisms of injury.
This work will have a positive impact by unraveling the mechanisms mediating coagulation-associated
abruption and will likely have implications for a broader set of placental complications.

Public health relevance
PROJECT NARRATIVE This work is relevant to public health because placental abruption can kill the mother and the fetus or cause immediate and long-term health problems for babies born from pregnancies with abrupted placenta. In pregnancies with placental abruption, the mother is at risk of uncontrollable bleeding and the fetal complications include intrauterine growth restriction, low birth weight, stillbirth, spontaneous and medically required preterm delivery. The proposed research investigates novel cellular mechanisms that mediate the onset and development of placental abruption and thus advances NIH’s mission by finding ways to diagnose and treat the problem.